Mechanisms linking the plasminogen/fibrinogen axis to the pathogenesis of COVID-19

SUMMARY
Severe Acute Respiratory Syndrome Coronavirus-2 (SARS-CoV-2; CoV2) is the first highly pathogenic and
highly transmissible human coronavirus that is the causative agent for the worldwide COVID-19 pandemic. As
of November 2020, 50 million cases of CoV2 infection worldwide and 1.25 million deaths have been reported.
The U.S. accounts for the majority of cases, 9.7 million (20%) and deaths 235,000 (19%), and COVID-19 is
expected to add an $8 trillion burden to the U.S. health care system. A particularly challenging aspect of
clinical management is the variable patient response to CoV2 infection. Some infected individuals report few
symptoms whereas others display severe disease characterized by hypoxia, acute respiratory distress
syndrome, and multi-organ involvement that can lead to death. A pro-inflammatory ‘cytokine storm’ in COVID-
19 patients promotes derangements in vascular function and blood composition. Elevated fibrinogen and D-
dimer (the breakdown product of fibrin clots) track with significant elevations inflammatory markers (e.g., IL-6,
C-reactive protein), which significantly and positively correlate with poor patient outcomes. Autopsy studies of
COVID-19 patients have revealed intravascular and extravascular fibrin deposits in lung tissue and other organ
systems. A current critical knowledge gap is the molecular basis of how persistent fibrin deposits develop and
whether they are functionally linked to the pathophysiology of severe COVID-19 disease. Our central
hypothesis that an insufficiency in the plasminogen activation (PA) system is a trigger point for transition of
COVID-19 from mild to severe disease due accumulating, proinflammatory, and tissue-damaging fibrin
deposits within the lung and other organ systems. To test this hypothesis, our research team developed a
mouse-adapted CoV2 virus that replicates key immunological and hematological aspects of COVID-19 in
humans. This unique tool will be used in conjunction with mice carrying single or combined deficiencies or
functional mutations in fibrinogen or PA system components to define the natural course of hemostatic
changes following infection and elucidate functional contributions of coagulation and fibrinolytic factors to the
host response. Specifically, we will determine (i) the differences in local and systemic activity of host factors
that control fibrin(ogen) deposition, stabilization, and dissolution following mild vs. severe CoV2 infection; (ii)
how PA deficiency promotes severe disease following CoV2 infection characterized by exacerbation of local
and systemic inflammatory, organ damage, and host mortality; and (iii) the mechanisms linking fibrin(ogen) to
exacerbation of host inflammatory responses and induction of severe disease following CoV2 infection. The
proposed studies will provide novel insights into the contribution of the plasminogen/fibrinogen axis to the
CoV2 pathobiology, illuminate key mechanisms coupling deficiencies in PA system components to CoV2-
mediated thrombophilia, tissue damage, and loss of organ function, and provide essential proof-of-principle
data to facilitate translation of findings into new treatments for COVID-19.

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic is caused by the Sars-CoV-2 coronavirus that has infected over 40 million people worldwide, has resulted in >210,000 deaths in the U.S., and is expected to cost the U.S. health care system $8 trillion. The primary goal of the proposed research is to define the mechanisms by which dysregulation of the blood clotting system mediates severe COVID-19 disease. This research program is highly relevant to public health because it will foster creative discoveries for targeting clotting factors to develop improved therapies for treating Sars-CoV-2-infected patients to reduce COVID-19 morbidity and mortality.